Predoctoral Training Program in the Neurosciences

Project Summary/Abstract
Continuing support is requested for a broadly based predoctoral training program in the neurosciences at the
University of Cincinnati. The training program is intended to support a total of 6 students over their first 2 years
of graduate education. The major objectives of the training program are to: 1) equip students with a broad
foundation of knowledge in neuroscience, emphasizing mechanisms of disease and the problems that confront
effective diagnosis and treatment; 2) provide in-depth research training that emphasizes modern, innovative
approaches to understanding nervous system function and the ethical conduct of research; 3) facilitate
development of outstanding written and oral communication skills; 4) foster excellence in the dissemination of
research findings in the form of professional presentations and written manuscripts; and 5) prepare students
for continued success in a wide variety of scientific careers. In response to a strong endorsement of the
program in our recent reviews, the University of Cincinnati has made substantial financial commitments to the
neuroscience community, providing new funds for recruitment of new faculty and programmatic enhancement.
These additional funds supplement the already strong level of financial and administrative support from the
College of Medicine. The training faculty are active and well-funded, and share a strong commitment to
graduate education. Efforts of the institution and program faculty have resulted in maintenance of a strong
applicant pool from top universities and colleges, and the program has consistently matriculated outstanding
candidates from diverse backgrounds. Our trainees routinely land postdoctoral positions at prominent
institutions, and go on to successful careers in academia, industry, scientific publishing, regulatory affairs and
scientific policy, attesting to the strength and vitality of the training program. Recent initiatives include the
recruitment of additional faculty across our broad neuroscience base; the development of new opportunities for
students to gain teaching experience; changes to the neuroscience curriculum in response to recent advances
in the field and the changing needs of our students; using individual development plans to ensure strong
mentoring of all students; and the creation of an Alumni Seminar Series which further advances our goal of
providing trainees ample opportunity to understand the diversity of neuroscience career options available to
them. We anticipate that the graduates of our program will continue to play a major role in future research
efforts to discover mechanisms underlying pathology of the nervous system and to develop new strategies to
treat or prevent neurological disease.

Public health relevance
Neuroscience research is critical for development of strategies to prevent, diagnose and treat diseases of the nervous system. This broadly based training program is designed to provide the next generation of researchers with a solid foundation in the fundamentals of neuroscience and strong, cutting-edge research training in basic and translational neuroscience, emphasizing rigorous experimental design and data analytic approaches.